Cherokee Nation Native AmericanResearch Center for Health

PROJECT SUMMARY
Through the RADx-UP program, the Cherokee Nation Community-Driven Program for Testing and Contact
Tracing (Cherokee PROTECT) unites tribal, academic, and community partners under the leadership of
Cherokee Nation (CN) to solve a dire need for COVID-19 testing, contact tracing, and culturally informed
education in underserved and vulnerable rural populations. As of August 4, Cherokee Nation Health Services
(CNHS) has confirmed >850 cases of COVID-19 in the tribal populations served across mainly rural
northeastern Oklahoma. Community spread of COVID-19 exists throughout all 14 counties in the CN
reservation, but with CN’s limited capacity for community testing, screening, and contact tracing, the true
impact of COVID-19 is unknown. Roughly 34% of American Indian/Alaska Native (AI/AN) adults aged 18-64
years are at risk of severe COVID-19 due to comorbidities, more than any other racial/ethnic group in the US.
Five counties in CN are in the top 20% of US counties for the prevalence of adults at risk of severe COVID-19
due to underlying medical conditions; this vulnerability is compounded by high poverty rates and geographic
barriers. People living in rural areas of CN may have to travel as many as 60 miles round-trip for viral testing.
Most COVID-19 testing in CN to date has been conducted through CNHS, the largest tribally compacted health
system in the US that serves all AI/AN people living within the CN reservation. Although CNHS accounts for
approximately 8.5% of all IHS active user population and 38% of active user population of Oklahoma service
area, not all tribal members residing in the reservation access CNHS, and therefore, may not be tested by
CNHS. Other than CNHS clinics, 7 of 14 counties in this area have only one public testing site, and results may
not be returned for 2-3 weeks. CNHS and its closely integrated CN Public Health program have an exemplary
20-year record of delivering public health interventions, including a groundbreaking Hepatitis C Virus
elimination program with the University of Oklahoma Health Sciences Center, and ongoing projects with >40
rural K-12 schools. Through collaborative clinical research and molecular studies, CN and the Oklahoma
Medical Research Foundation have identified new immune biomarkers in tribal populations. Drawing on these
existing strengths and infrastructure, Cherokee PROTECT will (1) Build infrastructure and increase FDA-EUA
COVID-19 viral and antibody testing for clinical care in CNHS; (2) Enable community-based COVID-19 testing,
contact tracing, and education with CN Public Health; (3) Identify barriers and facilitators to COVID-19 testing
in the CN reservation to inform a tailored educational campaign to increase testing and contact tracing, and
decrease spread; and (4) Implement a rigorous evaluation to ensure quality improvement and sustainability.

Public health relevance
NARRATIVE This Cherokee Nation-led, Community-Driven Program for Testing and Contact Tracing (Cherokee PROTECT) unites tribal, academic, and community partners to solve a dire need for COVID-19 testing, contact tracing, and culturally informed education in underserved and vulnerable rural populations in northeastern Oklahoma. Over one third of American Indian/Alaska Native adults aged 18-64 years are at risk of severe COVID-19, and this risk is compounded in rural communities. As part of the RADx-Up program, Cherokee PROTECT addresses immediate needs for COVID-19 testing and provides a foundation for future vaccination efforts.